Fatty acid remodeling of the translatome during fasting and aging

PROJECT SUMMARY/ABSTRACT
From Greek philosopher Plato to recent animal and human studies, fasting has been recommended as a strategy to
slow down aging and reduce the risk of many aging related diseases, such as insulin resistance, and type 2 diabetes.
Understanding how fasting signals elicit cellular programs that establish “anti-aging” benefits will provide new therapeutic
targets and strategies to prevent aging associated pathologies and expand healthspan. My findings show that during fasting,
hepatocytes selectively remodel the translatome to activate a specific translation network of many longevity-related genes,
which is overlooked by conventional transcriptomics analysis. This new mechanism involves a phosphorylation event of
the major cap-binding protein eIF4E, which was perceived as a general translation factor. Strikingly, upon fasting,
phosphorylation of eIF4E is activated and exquisitely induces target-specific translation, including mRNAs involved in lipid
and glucose metabolism, despite that global translation is downregulated. Genetically inhibiting eIF4E phosphorylation
leads to a reduction of ketogenesis and insulin sensitivity upon fasting or a fasting mimic diet. Furthermore, my preliminary
data revealed that fatty acids (FAs), which are elevated in the blood upon fasting, are novel signaling molecules that induce
the phosphorylation of eIF4E. These findings reveal a new paradigm for control of gene expression at the level of the
proteome downstream of FA signaling that establishes metabolomic reprogramming and health benefits during fasting.
Intriguingly, aging blunts this activation of eIF4E phosphorylation, and lack of eIF4E phosphorylation in mice exhibits
early markers of insulin resistance at middle age. Thereby, I hypothesize that FAs activate a signaling pathway, that
modulates the eIF4E-dependent translation network of mRNAs involved in ketogenesis and insulin pathway upon fasting.
I further posit that dysregulation of this pathway during aging may be responsible for aging related insulin resistance. The
specific aims of this project is to first identify the molecular mechanism underlying FA induced translation control, which
includes identifying the functional cis regulatory motifs in mRNAs that render their specificity during fasting (Aim 1.1) by
mutagenesis and functional assays, and revealing the upstream signals that are induced by FA (Aim 1.2) through unbiased
labeling or a pull-down system coupled with mass spectrometry (MS). Secondly, I will determine the functional role of
phospho-eIF4E dependent translation in aging associated insulin resistance (Aim 2.1). I will set up an aging mouse model
employing eIF4E phosphorylation mutant mice coupled to metabolic assays and translatome analysis to detect how
phospho-eIF4E dependent translation control affects insulin sensitivity upon aging. I will also set up an aging cell model to
determine the mechanisms underlying the aging induced loss of activation of eIF4E phosphorylation upon fasting (Aim
2.2). This work will improve our understanding of FAs as signaling molecules that dynamically regulate cellular functions,
reveal a mechanistic link between fasting and aging-related diseases, open exciting avenues of research in understanding
the role of translation control on aging induced physiological changes, and identify novel therapeutic targets for aging
related metabolic diseases. This research will be carried out within the highly collaborative environment of UCSF and
supported by a multidisciplinary advisory committee with expertise in translation control, MS, aging, and diabetes.

Public health relevance
PROJECT NARRATIVE: From ancient to modern times fasting has been recognized as an effective way to improve health, slow down aging, and reduce the risk of many aging-related pathologies, such as insulin resistance; yet it is unclear how fasting establishes those benefits at molecular levels. My data provide evidence for the existence of a novel gene expression network that regulates metabolic reprogramming upon fasting; however, this pathway is blunted during aging, and disruption of this pathway may lead to aging related insulin resistance. Characterizing this novel pathway will lead to the identification of new therapeutic targets for aging related insulin resistance and type 2 diabetes.